Development of a universal gene therapy for hemophilia A or B with or without inhibitors

Summary/Abstract
Hemophilia is an inherited bleeding disorder caused by a deficiency of the functional clotting factor FVIII
(hemophilia A) or FIX (hemophilia B) in the contact activation pathway of the coagulation cascade. Current
treatment by protein replacement therapy is constrained by the short half-life of the clotting factors, requiring
repeated infusions at relatively large doses. The development of inhibitors (alloantibodies to clotting factors)
remains the single most important obstacle to managing hemophilia with protein therapy. Approximately 20–30%
of patients with hemophilia A and 5% of patients with hemophilia B develop inhibitors after protein replacement
therapy. In patients with inhibitors, the administration of clotting factors is ineffective, and poor control of
hemorrhagic episodes increases complications associated with the disease. Bispecific Factor IXa and X-directed
antibodies can be given to hemophilia A patients with or without inhibitors and are an improvement over infusions.
However, 47% of patients still require infusions for breakthrough bleeds. Hemophilia A gene therapies using
Adeno-associated virus (AAV) to deliver FVIII, either approved or in development, for non-inhibitor patients have
demonstrated limited durability of effect after a single infusion. Importantly, to date there have been no approved
AAV based gene therapies in development for hemophilia patients with inhibitors.
GeneVentiv is directly addressing this critical unmet need through the development of GENV-HEM, the first
designed to treat inhibitor patients. GENV-HEM is an AAV8 vector encoding human FVa (hFVa) driven by a liver-
specific promoter. Within the coagulation pathway, FVa functions downstream as a co-factor of activated Factor
X (FXa) to amplify thrombin generation. FVa acts in the common coagulation pathway and can generate thrombin
via the prothrombinase complex without FVIII or Factor IX, or in the presence of anti-FVIII or anti-FIX antibodies.
Because of the position of FVa in the coagulation cascade, GENV-HEM offers a potential platform (universal)
therapy that can treat all types of hemophilia. We have demonstrated proof-of-concept of GENV-HEM in mouse
models of hemophilia A or B with or without inhibitors. The next major steps toward commercialization of this
innovative technology are encompassed in the following Specific Aims: (1) Optimization of lead GENV-HEM
candidate in a mouse model of hemophilia to reduce the minimum effective dose; (2) Manufacture GLP-grade
GENV-HEM for IND-enabling studies; (3) Demonstrate efficacy of GENV-HEM in a canine model of hemophilia;
and (4) Develop bioanalytical methods in nonhuman primates in preparation for IND-enabling
pharmacology/toxicology studies. This application requests supplemental TABA funding to provide
Regulatory support and guidance to prepare for our FDA INTERACT meeting and additional IP filing
resulting directly from the parent Phase II SBIR. As an early-stage startup, our regulatory and IP budget is
limited for these critical activities towards completing a successful round of financing and eventual
commercialization. Support for regulatory and IP filing activities will increase the ultimate value of our enterprise.

Public health relevance
Narrative Current treatment of hemophilia by protein replacement therapy is constrained by the short half-life of the clotting factors, requiring repeated infusions at relatively large doses. Approximately 20–30% of patients with hemophilia A and 5% of patients with hemophilia B develop antibodies against the infused factors (termed inhibitors) after protein replacement therapy, which remains the single most important obstacle to managing hemophilia. In patients with inhibitors, the administration of clotting factors is ineffective, and poor control of hemorrhagic episodes increases complications associated with the disease. GeneVentiv is directly addressing this critical unmet need through the development of GENV-HEM, the first universal gene therapy for all hemophilias and the first designed to treat inhibitor patients.